Expanding Excellence in Developmental Biology in Oklahoma

ABSTRACT
Our overall goal is to strengthen our Developmental Biology COBRE by mentoring five newly-recruited
investigators, each studying important questions in Developmental Biology with translational implications. We
will build upon our success in Phase I when our COBRE Investigators made important discoveries resulting in
53 published papers (many in high-impact journals), 91 presentations at invited seminars or scientific
meetings, and the awarding of more than $9.75 million in external funding, including 3 R01s and a R56. We will
also continue to build our infrastructure by strengthening and expanding our scientific Cores. Developmental
Biology is fundamental to progress in determining the molecular basis of many diseases, as well as for the
rapidly emerging field of regenerative medicine. Our new Junior Investigators will use a variety of experimental
model systems to explore fundamental developmental processes that are compromised by disease, or might
be manipulated to promote healing. Their research areas include intestinal regeneration (planarians), stress
responses and aging (C. elegans), mucous cell hyperplasia leading to chronic obstructive pulmonary disease
(human cell culture and mouse models), genetics of deafness (zebrafish), and neurodegenerative diseases
(Drosophila). The addition of five new Junior Investigators will help create the critical mass necessary for a
sustainable community where Developmental Biologists can flourish. Phase II COBRE support will allow us to
implement an ideal program for launching the careers of these new investigators by providing committed
mentoring from internal and external scientists, building and maintaining outstanding Core facilities for
advancing Developmental Biology research, and integrating the new investigators into the growing
Developmental Biology community in Oklahoma. This will be accomplished through the following Specific
Aims:
Aim 1. To grow our multi-disciplinary research program in Developmental Biology through the nurturing of a
talented group of Junior Investigators with outstanding potential to become leaders in their fields
Aim 2. To mentor the Junior Investigators, using a combination of senior scientists and recently graduated
COBRE Junior Investigators within existing OMRF and University of Oklahoma faculty
Aim 3. To form an External Advisory Committee of internationally recognized Developmental Biologists to
evaluate the progress of, and offer advice to, the Junior Investigators
Aim 4. To maintain and expand Core facilities that will support the research of the Junior Investigators and lay
the groundwork for their sustainable operation after COBRE funding ends.
Aim 5. To promote scientific interactions among the Junior Investigators and create an environment conducive
to investigator retention.

Public health relevance
Narrative The five highly talented Junior Investigators in this Phase II COBRE will use model organisms to study fundamental issues in Developmental Biology with direct relevance to human health. These include mechanisms of intestinal regeneration (planarians), cell fate decisions in the development of chronic obstructive pulmonary disease (mice), genetics of deafness (zebrafish), transcriptional control of longevity (C. elegans), and mitochondrial dynamics in neurodegenerative diseases (Drosophila).